Food FARMacia: Reducing Childhood Obesity in Households with Food Insecurity

ABSTRACT
Childhood obesity remains highly prevalent and originates early in life. Efficacious early life interventions to
prevent childhood obesity are lacking, particularly among populations most burdened by childhood obesity.
Food insecurity - defined as lack of enough food for an active, healthy life – may play key upstream roles in
etiologies of obesity through establishment of unhealthy dietary patterns and stress-related metabolic
perturbations. Household food insecurity during the first 24 months of life is a risk factor for later childhood
obesity. Professional organizations recommend integration of household food insecurity screening into routine
pediatric primary care. Yet, a critical gap exists in identification of efficacious clinical interventions to reduce
food insecurity. Another gap exists in understanding relationships between food insecurity and etiologies of
obesity. Food FARMacia is a clinically based mobile food pantry intervention developed to address the high
prevalence of food insecurity among pediatric patients. No randomized trials of a clinically-based mobile food
pantry intervention in pediatric primary care exist. To understand the role of food insecurity in etiologies of
childhood obesity, efficacious interventions to reduce food insecurity are needed. To test efficacy of the Food
FARMacia intervention in a randomized clinical trial (RCT), feasibility of RCT procedures must first be
established.
The overall goal of this study is to perform a Phase IIb pilot and feasibility RCT of the Food FARMacia clinically
based mobile food pantry intervention to promote healthy weight during infancy compared to an attention
control over 6 months. We will recruit 70 families (randomized n = 35 infant-parent dyads per arm) with an
infant age 6 to <18 months and food insecurity identified on routine electronic health record screening at
pediatric primary care visits in our multi-site urban academic health care system. We will examine feasibility
and acceptability of the RCT procedures and intervention components using quantitative and qualitative
research methods. We will estimate the effects of the intervention on infant weight characteristics over time to
inform a full-scale trial. We will explore potential mediators of intervention effects, including household food
insecurity. Our multidisciplinary team has expertise in childhood obesity, nutrition, community-engaged, and
population health research; clinical trials; qualitative research; and biostatistics. Results will immediately inform
a full-scale Phase III RCT to test the efficacy of the Food FARMacia intervention on preventing childhood
obesity. Results of a full-scale trial will also provide new information about relationships of household food
insecurity during infancy and etiologies of obesity. If successful, this research will accelerate identification of
scalable, efficacious clinical interventions to transform clinical care for reduction of food insecurity and
promotion of healthy infant growth.

Public health relevance
NARRATIVE Household food insecurity during infancy is a risk factor for later childhood obesity. In this pilot and feasibility study, we will randomly assign infant-parent dyads with household food insecurity to either 1) the Food FARMacia mobile food pantry intervention with self-directed meal preparation support or 2) self-directed meal preparation support. In addition to examining feasibility, acceptability, and satisfaction, we will estimate intervention effects on infant weight characteristics and explore potential mediators to inform a subsequent full- scale trial.